Latent TGF-β2 Structure and Activation

Abstract. Transforming growth factor β2 (TGF-β2) is critically important for heart and vascular development
and repair. TGF-β2 dysregulation is seen in patient TGF-β2 mutations, systemic sclerosis, and Kawasaki
disease, which have cardiovascular sequelae such as aortic aneurysms and cardiac fibrosis. TGF-β1, 2 and 3
are synthesized as proproteins that dimerize and associate with milieu molecules that regulate TGF-β tissue
localization, such as the transmembrane protein glycoprotein A repetitions predominant (GARP) and latent
TGF-β binding proteins (LTBPs) in the extracellular matrix (ECM). Proconvertases cleave between the
prodomain and growth factor (GF) domain; however, the prodomain dimer remains non-covalently associated
with the GF in a proTGF-β–milieu molecule complex after secretion. ProTGF-β–milieu molecule complexes are
inactive because the prodomains encircle the GF and prevent binding to TGF-β receptors. ProTGF-β1 and 3
activation is mediated by binding of integrins αVβ6 and αVβ8 to an RGD-motif in the prodomain and requires
proTGF-β association with a milieu molecule. How proTGF-β2, which lacks an RGD-motif, is activated remains
a mystery. Aim 1 will define the structure of proTGF-β2 to understand its mechanism of latency. Aim 2 will
determine proTGF-β2/milieu molecule complex structures by X-ray crystallography and cryo-EM to define how
milieu molecules bind and alter TGF-β2 latency. We will generate antibodies to use as crystallization
chaperones in addition to using already developed nanobodies to proTGF-β2. Complementary unfolding
studies will test the hypothesis that milieu molecule binding stabilizes proTGF-β2. Aim 3 characterizes TGF-β2
activation. Follow-up studies will identify cell-lines that natively activate TGF-β2 and characterize the
physiologically relevant process. The results of this grant will enhance our understanding of TGF-β2 latency
and activation in extracellular milieus and lay the foundation for developing therapeutics that target proTGF-β2
and its physiologically relevant complexes with milieu molecules.

Public health relevance
Project Narrative Transforming growth factor beta2 (TGF-β2) is an important secreted protein that directs the proper development and functioning of the cardiovascular system. Disruption of TGF-β2 is associated with disorders such as Loeys-Dietz Syndrome Type 4, scleroderma, and Kawasaki disease that can cause severe defects in the heart and blood vessels. This grant will deepen our structural and biochemical knowledge of how TGF- β2 is activated in the body and will have broad implications for our understanding of these diseases while setting the stage for the development of new therapeutics.